Interrogating drivers of plasticity in early lung cancer tumorigenesis and metastatic dormancy.

PROJECT SUMMARY/ABSTRACT
Cancer is often diagnosed at advanced stages when tumors are highly heterogeneous, aggressive, and have
metastasized, limiting the effectiveness of current therapies and leading to patient relapse. This is particularly
true of lung adenocarcinoma (LUAD), which accounts for 7% of global cancer mortality. Targeting early, less
heterogeneous lung neoplasias could offer curative potential, yet the mechanisms driving early tumorigenesis
in vivo are poorly understood. Notably, plasticity—the ability of cancer cells to undergo state transitions via
non-genetic mechanisms—plays a critical role in cancer initiation, progression, metastasis, and therapy
resistance. Recent work in our lab identified a highly plastic cell state (HPCS) in primary LUAD tumors that
drives tumor heterogeneity and therapy resistance. Understanding the drivers of phenotypic plasticity during
early tumor progression and metastatic dormancy is essential for developing strategies to intercept early
tumorigenesis and prevent the outgrowth of disseminated tumor cells, ultimately improving patient outcomes.
My predoctoral research (Aim 1) focuses on identifying the molecular mechanisms driving plasticity in early
lung cancer tumorigenesis in vivo. A focused in vivo CRISPR screen targeting genes specifically expressed in
HPCS cells revealed several candidates, including uPAR and EPCR, as drivers of early LUAD tumorigenesis.
Therefore, the objective of Aim 1 is to validate uPAR and EPCR as drivers of phenotypic plasticity in HPCS
cells and investigate the underlying molecular mechanisms during early tumor progression. Targeting these
early mechanisms could lead to effective new therapies for preventing lung cancer in high-risk individuals. My
postdoctoral research (Aim 2) will focus on exploring the regulators of metastatic dormancy using a
spontaneous metastasis mouse model. ScRNA-sequencing and spatial transcriptomics will identify candidate
transcriptional programs and cellular neighborhoods linked to dormancy. Aim 2 seeks to uncover molecular
mechanisms that drive phenotypic plasticity and metastatic outgrowth from dormant cells, using genetic and in
vivo imaging tools to elucidate and validate key regulatory mechanisms. The overarching hypothesis is that
targeting plasticity in disseminated tumor cells can inhibit their transition to overt macrometastases. Together,
these two aims lay the foundation for developing therapies targeting plasticity, with the potential to improve
outcomes for patients at high risk of developing lung cancer and those with existing advanced metastatic
disease. Furthermore, our findings could extend beyond LUAD, offering insights applicable to other cancer
types characterized by phenotypic plasticity and metastasis. This research will be conducted in Dr. Tuomas
Tammela’s laboratory at Memorial Sloan Kettering Cancer Center (MSKCC), one of the world's leading cancer
research and treatment institutions. The state-of-the-art resources and collaborative environment at MSKCC,
along with support from the Gerstner Sloan Kettering Graduate School, offer an ideal setting to ensure the
successful completion of my research and career development goals.

Public health relevance
PROJECT NARRATIVE Plasticity–the capacity for cell state transitions via non-genetic mechanisms–plays a key role in cancer initiation, progression, and therapy resistance. My predoctoral research focuses on identifying molecular drivers of plasticity in early lung cancer tumorigenesis in vivo, aiming to intercept cancer development in high-risk individuals such as smokers. Furthermore, my postdoctoral research will reveal cancer cell-intrinsic and cell-extrinsic determinants regulating plasticity in metastatic dormancy in mice, with the goal of identifying targetable vulnerabilities for the prevention of advanced metastatic disease in patients.